Early-onset Alzheimer’s and other dementia: From natural history to clinical trials

PROJECT SUMMARY
Approximately 5.8 million Americans age 65 and older have Alzheimer's disease, and this number is expected
to increase to 13.8 million by 2050. While most develop diagnosable symptoms at or over the age of 65 (e.g.
late-onset), 5-10% develop symptoms at age 64 or younger and are classified as early-onset. Early- and late-
onset Alzheimer's disease share the same pathologic substrate, but there are critical differences in their clinical
presentations, biological phenotypes, and life impact. Moreover, early-onset dementia is more likely than late-
onset dementia to be caused by pathologies other than Alzheimer's, including vascular, Lewy body, and
frontotemporal degeneration. Because of their young age and atypical symptoms, early-onset patients often
face a significant delay to diagnosis. Dementia onset at such a young age also has disproportionately
devastating financial and emotional consequences for patients, families, and society. Due to age restrictions or
absence of memory deficits, early-onset patients are under-represented in ongoing largescale genome and
observational biomarker studies and in therapeutic trials. To date, no large-scale clinical trials have specifically
addressed early-onset MCI and dementia. The Alzheimer's Association (AA) proposes to create and
implement a two-day conference, to be held annually for 3 years, entitled Early-Onset Alzheimer's and Other
Dementia: From Natural History to Clinical Trials. Patients, carers, and family members will be involved in the
planning, implementation, and evaluation components of the conference. The short-term goal of the
conference is to create a forum for discussion of research, trial design, drug development, and other concerns
among key stakeholders. The long-term goal is to increase the likelihood, quality and patient-centeredness of
future clinical trials addressing early-onset MCI and dementia. A Conference Workgroup made up of the PI and
collaborators, additional leading experts in dementia, and individuals with early-onset MCI or dementia and/or
their family members will develop, implement, and oversee all conference, evaluation, and dissemination
activities. The conferences will be held in coordination with the annual Alzheimer's Association International
Conference (AAIC) and offer didactic, panel discussion, and poster based formats, as well as face-to-face
networking opportunities, anticipating 250 attendees. Lunch poster sessions dedicated to the early career
investigators will be held on both days of the conference, and multiple approaches will be used to ensure
diversity amongst speakers and attendees. Dissemination efforts will include webinars, press releases, social
media highlights, and manuscripts documenting conference proceedings and findings.

Public health relevance
NARRATIVE Of the close to six million Americans and their families affected by dementia, 5-10% are early-onset (before the age of 65), and these numbers are expected to increase. Early onset dementia differs from late-onset in its clinical presentation, biological phenotypes, and life impact, yet to date, no large-scale clinical trials have specifically addressed early onset dementia. To increase the likelihood, quality, and patient-centeredness of future clinical trials, the Alzheimer's Association proposed to develop and host an annual 2-day conference, to include patients and families, entitled: Early-Onset Alzheimer's and Other Dementia: From Natural History to Clinical Trials.